Single session CBT-Informed Treatment for Loss of Control Eating during Pregnancy: A Pilot Feasibility Study

Abstract
Affecting 50% of pregnant women in the US, excess gestational weight gain (eGWG) has broad and lasting
adverse impacts on both maternal and child health. A potentially key modifiable target for the prevention of
eGWG is loss-of-control (LOC) eating, a disordered eating behavior characterized by the perceived experience
of being unable to control what or how much one is eating, regardless of the amount of food consumed. There
is a strong evidence base supporting cognitive-behavioral therapy (CBT) approaches for reducing LOC
eating, yet there are currently no pregnancy-focused interventions that target LOC eating. However, CBT can
be resource-intensive, costly, lasts several months in duration, and often requires providers with specialized
training. Given these critical challenges, developing novel, brief, and evidence-based approaches to targeting
LOC eating during pregnancy is a crucial step towards addressing eGWG. Virtual single-session interventions
(SSI) that deliver the central theory-driven components of longer interventions represent an innovative
approach that balances time and resources with public health impact, yet have not been adapted for LOC
eating or pregnancy. To fill this gap, I desire to become a leading independent investigator with a research
program focused on the development, implementation, and evaluation of interventions to prevent and treat
eating and weight behaviors, but require additional training. The NIH Mentored-Patient Oriented Career
Development Award will provide protected time to seek this training and further my skills and ability to
implement the proposed research. My short-term training goals are to develop advanced expertise in (1)
mixed-methods and qualitative research design, (2) implementation science theory and methods, (3) clinical
trial design and implementation. I have developed a strong training plan and mentoring team, led by Drs.
Marian Tanofsky-Kraff (co-primary mentor), Jason Lavender (co-primary mentor), Jessica Schleider (mentor),
and Paige McDonald (mentor), and a team of expert consultants. RESEARCH STRATEGY: The objective of
the study is to design and evaluate the acceptability and preliminary efficacy of a virtual CBT-informed SSI for
LOC eating during pregnancy. The study will follow the Knowledge-to-Action Framework that guides
implementation science to conduct a two study proposal. Study 1: I will engage pregnant women who
experience LOC eating to identify barriers and facilitators to detecting and treating LOC eating, and use their
input to design a virtual SSI. Study 2: Participants will be randomized to either the SSI or an information-only
condition. This training and research plan will form the basis for a future clinical trial testing the efficacy of the
SSI for improving LOC eating and weight outcomes during pregnancy, to be proposed in an R01 grant
application before the end of the K23 award.

Public health relevance
PROJECT NARRATIVE Loss of control (LOC) eating is a key mechanism of excess gestational weight gain (eGWG), yet no prior eGWG interventions address it. Cognitive-behavioral (CBT) approaches are the first-line treatment for LOC eating, yet can also be costly and resource-intensive. This project will develop and pilot a virtual CBT-informed single-session intervention to reduce LOC eating and mitigate risk for eGWG during pregnancy.